P30 Center Core Grant for Vision Research

ABSTRACT
Administrative Core
The Administrative Core is responsible for all administrative and oversight activities related to the NEI P30
Vision Core grant. Responsibilities include providing administrative support for core facilities and equipment to
NEI R01-funded and other vision researchers and their laboratory members, preparing and submitting all
required reports to the National Eye Institute, arranging all meetings related to any aspect of administration of
the Vision Core grant, handling all financial matters related to the Vision Core grant (purchasing of supplies for
each core, ensuring that all service contracts are paid in a timely manner, preparing monthly financial reports
for each core, communicating with OU Financial Services on behalf of the cores regarding billing), and liaising
with the administration of the Department of Ophthalmology and OUHSC on all matters relevant to the
successful operation of the P30 Vision Core grant. The Administrative Core established over the last decade
has supported OUHSC vision research at an exceptional level, and we anticipate this excellent level of support
to continue during the next funding period.